Analysis of mouse models of premature glial senescence

Project Summary
CNS glial cells, including oligodendrocytes, astrocytes and microglia, regulate neuronal function. Although much is known
about their importance in the developing and adult CNS, a gap in knowledge remains with regards to how aged glia
contribute to remyelination failure and neurodegeneration. This is particularly relevant to age related neurodegenerative
disorders, such as secondary progressive multiple sclerosis (MS), Alzheimer’s disease (AD), and Parkinson’s disease (PD)
in which glial dysfunction and chronic inflammation within the CNS, are common features. In order to fully understand the
impact of aged glia on CNS function, the goal of this project is to characterize novel models of CNS glial senescence in
mice and examine their impact on CNS function and repair.

Public health relevance
Project Narrative CNS glial senescence occurs with advanced age and corresponds with increased CNS dysfunction. This project will develop and characterize new mouse models of glial senescence. The results of this study would improve our understanding of the impact of glial senescence on brain health, which could lead to the development of novel disease modifying therapies, targeting glial senescence, to prevent or reverse age-related neurological diseases.